Core C: Immune Monitoring Core

Project Summary/Abstract
This CCHI U19 Program aims to determine how perturbations of the human immune system leads to do durable
changes that impact future immune responses. Core C of this Immune Perturbation Study Group Program
application will be central to the scientific efforts of this consortium. A unique and comprehensive pipeline has
been created alongside an expansive repository of existing samples and background data to measure and
analyze high dimensional immune landscapes using quantification of all circulating immune cell types with
activation status, serology and systemic inflammation over the course of different perturbations outlined in the
Projects. This pipeline will be maintained and expanded to include additional longitudinal samples from subjects
with post-acute sequalae of COVID-19 (Project 1), subjects cured of HCV (Project 2), and subjects receiving
vaccines during anti-PD-1 therapy (Project 3). This concerted effort will maintain high throughput of immune
phenotyping to catalyze scientific efforts across the consortium, including analyzing samples accrued by Core
B. Thus, Core C provides a central and integrative service that will allow studies in the different Projects to inter-
relate around immune landscapes during immune perturbation.

Public health relevance
Project Narrative Non-genetic influences, like viral infections and environmental factors, shape the human immune system. It is not, however, clear how this heterogeneity influences responses future events, like vaccination or immunotherapy. Core C will perform high dimensional immune profiling with integrated analysis on all clinical samples to identify immunotypes associated with disease.